Brain Vascular Plasticity in the Context of Peripheral Painful Trauma

SUMMARY
The PI proposes a high-impact multidisciplinary research project investigating the effects of brain microvascular
anatomy and function on neuronal and glial plasticity in a mouse model of peripheral neuropathy.
Chronic pain is a heavy burden for the individual and society, affecting 30% of the adult population in the USA,
and presenting with multiple co-morbid psychiatric disorders, including mood alterations and cognitive
impairment. One pivotal mechanism that could explain the chronification of pain as well as its resistance to
classical treatment is the concept of pain centralization, where initial sensory events can gradually alter the
central nervous system, resulting in amplified pain and/or aberrant pain that exists without peripheral
sensitization. Alterations in brain circuitry have been well reported across a spectrum of pain conditions, such as
complex regional pain syndrome, fibromyalgia, neuropathic pain, and migraine, thus prompting the quest for
treatments that could reset these systems. However, most of the research in this area overlooks the evolving
brain microvascular changes that may parallel cellular plasticity.
Our long-term goal is to delineate brain vascular alterations (permeability, anatomy, and perfusion) and the
associated changes in neurons and glia that parallel the progression of peripheral neuropathy. This approach
goes beyond attempting to mask the experience of pain via pharmacotherapy (including addictive opioid
treatment) and seeks to understand the mechanistic underpinnings of pain chronification via (mal)adaptive brain
alterations. Specifically, we aim to 1: Characterize the anatomical and histological signs of blood-brain-barrier
permeability following peripheral neuropathy. 2: Identify changes in brain micro-vascularization following
peripheral injury. And 3: Characterize the effect of brain vascular plasticity on neuronal and glial abundance and
function.
While it is understood that pain is a subjective experience that ultimately resides in the brain, there is no
characterization of how an injury to the limb causes long-term brain alterations, and for many patients, a lifetime
of pain and suffering. This proposal outlines a path by which trauma to peripheral tissues can cause long-lasting
behavioral and brain plasticity via vascular mechanisms.
This proposal will enhance the infrastructure of research and education at Queens College, introducing
biochemical and biomedical research experiences to underrepresented minority and female students, who would
otherwise lack such opportunities. This would allow them to experience a broad spectrum of techniques, and
acquire skills such as small animal surgery, behavioral testing, and advanced biochemical analyses.

Public health relevance
NARRATIVE Chronic pain is a disabling condition that is accompanied by neuropsychiatric comorbidities such as anxiety, depression, and cognitive decline. While the peripheral alterations are well-studied, we lack an understanding of how these peripheral changes can result in long-lasting brain alterations and the ensuing behavioral phenotypes. Using a well-characterized mouse model of peripheral neuropathy, we propose to test the hypothesis that changes in brain vascular anatomy and function are major factors controlling supraspinal neuronal and glial plasticity that is a hallmark of chronic pain.